Extrafollicular B cell response regulation during influenza infection

PROJECT SUMMARY
Infection-induced B cell activation occurs in the context of complex innate immune responses, including
the elaboration of cytokines, and the remodeling of secondary lymph tissues draining sites of infection. Our
long-term objective is to determine how optimal protective humoral immunity to infections is induced and
maintained. Exploring infection-induced innate stimuli that modulate adaptive immunity, we showed that
infection-induced and TLR-agonist adjuvanted s.c. immunization provide required B cell intrinsic TLR
signaling via both adaptors (MyD88 and TRIF) for extrafollicular responses, as deletion of both adaptors
abrogated EF responses. While B cell intrinsic MyD88 stimulation drives B cell proliferation, TRIF signaling
does not, indicating distinct yet unknown mechanisms of TRIF-mediated support for EF formation. When
and where, during B cell activation, these innate signals regulate B cell fate is unknown. Recently we
identified an early induced, post proliferative, influenza specific B cell population with a unique phenotype
and transcript profile that might represent an activation intermediate of EF. The objectives for this project
are to test the hypothesis that early in influenza infection B cell intrinsic TRIF/TLR3 and MyD88-mediated
signals support EF differentiation via two distinct differentiation paths, each differently affecting
extrafollicular antibody quality, acting on antigen-stimulated, post-proliferative B cells. To achieve our
objectives, we will test in Specific Aim 1 the hypothesis that B cell intrinsic TLR3-signals support effective
plasmablast differentiation by enhancing B cell responsiveness to IL2, while MyD88 principally drives
proliferation followed by terminal differentiation, differentially affecting antibody quality. In Specific Aim 2
we will determine the extent to which the population of transcriptionally distinct, antigen-experienced,
mostly non-switched and post-proliferative B cells that appear in the draining LN at 5 dpi with influenza
virus, represent an intermediary, quiescent stage in B cell activation to EF, extrafollicular memory B cells
and/or GC development and determine the impact of TLR signaling on their development and fate.
Successful completion of the work would provide significant conceptual advances to understanding early
B cell activation and extrafollicular memory B and plasma cell response induction. It would also identify a
novel role for TLR3 in support of EF development and clarify the function of TLRs on B cell responses.
Collectively these advances would identify new, critical junctures in B cell activation, regulated by innate
immune signals for potential exploitation in vaccine design.

Public health relevance
NARRATIVE Vaccines against influenza virus infection induce protetive antibody responses. However, these vaccine-induced immune responses are often not as durable as seen after infection. In the proposal we are investigating factors that might be responsible for the better immunity induced to infection than to vaccination with influenza virus. By identifying these factors we hope to learn how we can generate vaccines that trigger longer-lasting and better immune protection.